Regulation of Sarcomere Growth

PROJECT SUMMARY/ABSTRACT
It is well established that the addition or removal of sarcomeres is central in determining muscle size and force
output during normal development, but also in response to mechanical stimuli or pathological conditions.
Overstretched muscle can initiate new sarcomere formation, while chronic understretching reduces sarcomere
number and may shorten muscle lengths. Other than disease states or mechanical-load induced alterations, few
studies have examined force-independent factors that influence skeletal muscle sarcomere remodeling.
Moreover, a major knowledge gap is understanding how muscle-intrinsic factors contribute to sarcomere
addition during muscle growth. To address these deficiencies, we have established genetic backgrounds that
promote larval muscle growth to quantitatively study serial sarcomere addition at a single-cell resolution in the
experimentally tractable Drosophila model. Completion of the following two aims will help us accomplish our
long-term goal of understanding how muscle length increases at both the sarcomere and whole tissue levels
during development and growth. Aim 1 will determine the identity of molecular targets that impact sarcomere
addition using transcriptomic and candidate approaches. Aim 2 will use in vivo protein tagging methods to follow
the fate of newly synthesized sarcomere proteins during muscle growth. We expect that this project will
fundamentally advance our understanding of signaling pathways required for sarcomere addition and will
establish new techniques for studying sarcomere dynamics.

Public health relevance
PROJECT NARRATIVE The link between muscle growth and the molecular-level events that precisely induce new sarcomere formation remain poorly understood. In this proposal we will integrate genetic models that alter sarcomere number and size with in vivo protein labeling approaches to visualize the spatiotemporal dynamics of new protein synthesis during muscle growth and homeostasis.